Quantifying adapted balance control during walking in chronic stroke

PROJECT SUMMARY
Post-stroke balance and gait impairments are a barrier to safe community ambulation for those with chronic
stroke. Although an important aspect of post-stroke rehabilitation is restoring a person’s ability to safely
ambulate in their community, many post-stroke individuals discharged from rehabilitation are still unable to
manage the varied demands of community ambulation. Our premise is that walking adaptability and the control
of balance during walking are interrelated factors that can be addressed to improve post-stroke rehabilitation.
Walking adaptability is assessed by the performance of complex walking tasks, defined as tasks that increase
motor and cognitive demands to a greater extent than simple overground walking. Although gait is a task with
concomitant demands on balance and mobility, studies of post-stroke walking adaptability have largely ignored
the mechanisms by which balance is controlled during complex walking. Control of the lateral acceleration of
the COM, an aspect directly influencing walking balance, is a function of three mechanisms that we can
quantify through biomechanical analyses: 1) foot-placement, 2) push-off, and 3) counter-rotation of the body
segments. Although we know stroke alters lower-limb control and propulsive capabilities during walking, it is
unknown how the contributions of these balance control mechanisms are affected by stroke. Furthermore, we
do not know how the contributions of each mechanism may change with increased task complexity that
constrains or places more demands on these mechanisms. Our study aims to 1) characterize the balance
control mechanisms of those with and without chronic stroke during unconstrained walking, 2) characterize the
balance control mechanisms of those with and without chronic stroke during complex walking tasks, and 2)
determine how walking adaptability is related to balance control mechanisms in those with chronic stroke. To
address the first aim, we will use biomechanical analyses to quantify the contributions of foot-placement and
push-off in controlling the lateral COM acceleration during unconstrained walking. To address the second aim,
we will use biomechanical analyses to quantify the contributions of foot-placement and push-off in controlling
the lateral COM acceleration during narrow-path and fast walking tasks. To address the third aim, we will
establish the relationship between the performance of complex walking tasks, and the change in contributions
of the balance-control mechanisms utilized during those tasks in those with chronic stroke. The results of this
study will provide evidence that balance mechanisms are different in those with chronic stroke, and that an
inability to alter the contributions of those mechanisms during complex walking tasks may be a barrier to that
task performance. This evidence would inform future work aimed at promoting safe community ambulation for
those with chronic stroke by targeting balance control as a means for improving complex walking performance.

Public health relevance
PROJECT NARRATIVE Post-stroke balance and gait impairments compromise walking adaptability, which limits safe community ambulation for those with chronic stroke. This proposal seeks to characterize how stroke and walking task complexity affect the biomechanical mechanisms for controlling lateral balance during walking, as well as to understand the interplay between walking adaptability and balance control mechanisms in individuals with chronic stroke. This work will provide an understanding of how improvements in complex walking performance may correspond with adapted balance control, minimizing a critical barrier to safe walking activity in the free- living environment for those with chronic stroke.